Building models and tools to integrate multiscale brain imaging and multi-omics data

Title: Building models and tools to integrate multiscale brain imaging and multi-omics data
Project Summary
Our recent work on integrative analysis of multiscale brain imaging and multi-omics shows added value in
disease subtyping and biomarker detection. However, the following significant challenges remain: (1) complex
interactions with linear and nonlinear features occur at multiple scales (e.g., interactomes) but are rarely
incorporated into multi-modal analyses, (2) existing integrative approaches combine multi-modal brain imaging
with multi-omics but exclude phenotypic traits and a priori biological knowledge, and (3) current predictive models
are not easily interpretable. Without models that combine complementary imaging and omics information to
accurately predict behavioral phenotypes and identify the key parameters and biomarkers that govern them, we
are unlikely to increase accuracy of disease risk prediction and improve patient outcomes with the determination
of the underlying biological mechanisms.
In the proposed research, we will address these challenges by (i) developing innovative methods and tools
for brain imaging, omics, and behavioral data integration and (ii) validating them in the context of mental health.
Our application is the clinically significant problem of defining and predicting multiple psychiatric disorders—
currently difficult, at best—with the driving vision of advancing brain research toward precision psychiatry. Our
multidisciplinary team with a decade of productive collaborations will address the following Specific Aims: (1)
Develop nonlinear modeling approaches to detect complex interaction networks within and across scales; (2)
Develop and validate phenotype-guided integrative approach to combine multiscale imaging and omics data
while incorporating biological knowledge; (3) Build an interpretable predictive model linking multiscale brain
imaging and omics data, including their complex interactions, with behavioral phenotype; and (4) Disseminate
multimodal data interaction and integration tools to the neuroimaging research community.
The proposed research will advance the field of neuroimaging by filling the gap in interpretable multimodal
data integration approaches for comprehensive brain imaging and multi-omics data analysis. The methods and
tools developed by this project will be used to predict clinical outcomes and classify psychiatric disorders via
their underlying biological mechanisms. By disseminating the tools and software to the research community, this
work will have a broad and sustained impact on individualized disease diagnosis and treatment.

Public health relevance
Public Health Relevance Statement The project will advance the field of neuroimaging by improving the methodology for muti-modal imaging and genomics data integration, providing predictive modeling of brain-phenotypes, and identifying important biological mechanisms. By disseminating the developed tools and software via open sources, the project can facilitate multi-modal brain imaging and genomics data analysis that is widely used by neuroimaging community.